Effect of GI 198745 on spermatogenesis on normal healthy male subjects

To examine the effects of GI 198745, if any, on sperm production, sexual function and bone loss. GI 198745 is a 5 alpha reductase inhibitor and is similar to finasteride marketed for treatment of BPH and male baldness.